Patient-Centered Serious Games for Remote Cognitive Training in Older Adults with Mild Cognitive Impairment

Project Summary/Abstract Mild Cognitive Impairment (MCI) is characterized by cognitive decline greater than expected from normal aging, which does not yet significantly interfere with the performance of activities of daily living. The therapeutic goal for MCI is to slow down the course of the disease progress and reduce the impact of clinical symptoms. There has also been a particular emphasis on non-pharmacological interventions because they can slow disease progression and are low cost, non-invasive, safe, and have no adverse side effects. Serious games have received great interests among researchers and clinicians as a promising, low-cost, non- pharmacological intervention tool that can help assess and train patients’ cognitive function in a variety of environments (e.g., in/outside the clinic). Serious games in healthcare represent digital applications focusing on educating, informing, and enhancing patients’ health by leveraging the entertainment components of video games. However, currently available solutions require substantial involvement of trained caregivers and clinicians to motivate patients to adhere to the intervention protocol, which acts as the key barrier to the widespread implementations of serious game-based interventions. To bridge these gaps, this project aims to develop a mobile-health (mHealth) technology designed to encourage the use of, and thereby maximizing the compliance to, serious game-based training in individuals with MCI outside the clinic. We plan to employ a tablet-based application ? namely Neuro-World ? composed of six serious games designed to stimulate working memory and selective attention, which is developed by our research team’s industrial partner. Fully leveraging the system’s ability to provide clinically meaningful insights related to patients’ cognitive performance from their gameplays, their progress over time, and their compliance behaviors (e.g., use frequency and duration), it is our ultimate research goal to develop an optimal, human-centered serious game platform that can motivate patients? to better adhere to the technological regimen. To accomplish this research goal, Aim 1 will focus on evaluating the preliminary efficacy of our serious games as a training tool to improve cognitive function. We will perform a small single-blind randomized controlled trial in 50 individuals with MCI who will be randomized either to the intervention group or the control group. In Aim 2, we will develop machine learning-based algorithms to derive clinically meaningful information regarding cognitive function from the game performance. Aim 3 will finally investigate the optimal design of the mHealth system to maximize patients’ compliance with serious game-based training via human-centered design approaches. We believe that outcomes of this project will open a new door leading to previously unexplored datasets and understanding of patient-technology interactions to promote positive behavior changes to enable self- administered, serious game-based cognitive training, which can form the basis of a wide range of future investigations of hemiparesis rehabilitation and personalized disease management.

Public health relevance
Project Narrative Mild Cognitive Impairment (MCI) is characterized by cognitive decline greater than expected from normal aging. Serious games have received great interests from researchers and clinicians as a promising, low-cost, non- pharmacological intervention tool that can complement the conventional therapeutic programs to help assess and rehabilitate patients' functional impairments in many environments (e.g., clinics, long-term care facilities, patients' homes). In this project, we propose to develop a human-centered mobile-health (mHealth) technology designed to encourage the self-administrate serious game-based training in patients with MCI outside the clinic.